ELEVATE Training Integration Core

ELEVATE Training Integration Core Abstract
Substance use disorder (SUD) is by far the leading cause of pregnancy-associated death in our community,
and it disproportionately affects American Indian and Alaska Native (AI/AN) and rural populations. Successful
response to this maternal death crisis demands community partnerships and transdisciplinary collaborations in
both clinical and research efforts. To achieve this paradigm shift, early-stage investigators (ESIs) from diverse
backgrounds must be trained to recognize SUD as a condition that lies at the intersection of bio-behavioral,
sociopolitical, and public health factors. We use an expansive definition of ESI to include investigators along
career pathways from students to junior faculty. The ELEVATE Training Integration Core will use a
combination of academic institutional resources and community partnerships to create opportunities for ESIs.
This diverse group of trainees will serve as a pool for our Training Program capstone: the ELEVATE scholar, a
mentored faculty research position with 75% FTE support from the University of Utah (U of U) Vice-President
for Research. The U of U academic resources include formalized research training opportunities available
through the Substance Use & Pregnancy – Recovery, Addiction, Dependence (SUPeRAD) Clinic; the Vice
President’s Clinical and Translational Research Scholar Program (VPCAT), the Program for Addiction
Research, Clinical Care, Knowledge and Advocacy (PARCKA); and Utah Center for Clinical and Translational
Science Institute (CTSI). The community partnerships include Utah Support Advocates for Recovery
Awareness (USARA) and collaborators from the Sacred Circle Clinic. Consistent with the ELEVATE Center’s
focus on dissemination and implementation science, the Center supported ELEVATE Scholar will enroll in the
Mountain States Community-Engaged Dissemination and Implementation Science Training Institute. All
ELEVATE Center investigators will serve as research mentors. David Turok, MD will lead the Program,
working in collaboration with Jasmin E. Charles, PA-C, co-founder and clinical director of SUPeRAD who will
coordinate research opportunities for ESIs across all Center projects. The ELEVATE research projects provide
a foundation and focus for aspiring researchers to 1) support the development of a culturally-integrated
perinatal SUD intervention for urban Native mothers by adapting the successful SUPeRAD model, 2) help
develop and execute a training package to mitigate bias and stigma against individuals with SUD, and 3) to
conduct and evaluate informant interviews in collaboration with the Utah Maternal Mortality Review Committee
in order to understand the family, systems and community-level contributors and the role of discrimination in
pregnancy related death. The ELEVATE Training Integration Core will grow a cadre of future leaders in Utah
with the skillsets needed to identify and investigate the most functional solutions to the complicated problems
around maternal SUD, as well as to disseminate these findings broadly.